CARDIAC PHENOTYPING OF ETS-1 KNOCKOUT MICE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. To perform comprehensive cardiac phenotyping of ETS-1 KO mice, and compare the phenotypes to those observed in the human chromosomal disorder Jacobsen syndrome (11q Terminal Deletion Disorder) Specifically, I am very interested in collaborating with you to have you perform cardiac MRI analysis of my genetically engineered ETS-1 knockout mice. We have already shown that they have large ventricular septal defects, and I am very interested in determining, through 3-D MRI analysis, whether they might have any additional heart defects. I hope the analysis will be able to include an examination of the coronary arteries and pulmonary veins. Most of the KO mice have large ventricular septal defects (by histopathologic analysis). We want to use MRI to more comprehensively define the 3-D anatomy of these embryos, including ideally coronary artery and pulmonary vein anatomy.